Diversification of cell types in the Drosophila retina - Resubmission - 1

Summary
The development of a complex organ such as the eye involves the specification of multiple distinct
cell types and the integration of their functions. In Drosophila, the light-detecting photoreceptors and the
glial-like cone and pigment cells that secrete the lens and produce screening pigments arise from a single
field of equivalent progenitors. Commitment to one of these cell fates requires extracellular signals to be
integrated with a complex network of intrinsic transcription factors. Although receptor tyrosine kinase
signaling has been known for many years to induce both photoreceptors and cone cells, most of its target
genes remain unknown. It is also unclear which intrinsic transcription factors distinguish these cell identities.
The zinc finger transcription factor Glass had been thought to specify the photoreceptor fate, but our recent
work showed that it acts in each of the three cell types to promote their normal differentiation. This proposal
seeks to understand how these common factors activate distinct differentiation pathways. The first aim will
look for direct target genes of receptor tyrosine kinase signaling and Glass during retinal differentiation.
Targeted DNA adenine methyltransferase identification (DamID) will be used to identify direct target genes
of Pointed, the transcription factor that mediates Epidermal growth factor receptor (EGFR) signaling, in
undifferentiated cells, photoreceptors and cone cells. A similar approach will be used to identify Glass target
genes, and both datasets will be compared to transcriptomic analysis of genes that change their expression
in Egfr or glass mutants. The goal of these experiments is to identify transcription factors that are induced
by EGFR signaling to promote the differentiation of photoreceptors and cone cells, and elucidate how Glass
feeds into their regulation. The second aim concerns how transcriptional repressors restrict the effects of
Glass to drive cell type-specific gene expression. Two defined regulatory regions that are known to drive
photoreceptor-specific expression in a Glass-dependent manner will be used to identify repressors that
prevent Glass from activating these genes in cone and pigment cells. The importance of these repressor
binding sites will be tested in the endogenous genomic context. In a complementary approach, enhancer
regions that drive Glass-dependent expression specifically in cone or pigment cells will be identified and
their regulation characterized. In combination, these experiments will reveal how distinct cell identities can
be specified from common progenitors using a limited set of signals and transcription factors, a process that
also occurs in the mammalian retina. The results will help to refine our ability to produce specific cell types
from stem cells for regenerative medicine.

Public health relevance
Narrative Organs are built from multiple cell types that must be specified and integrated into a functional unit. In order to understand how cells choose their fates and develop different functional capacities, this proposal will determine how interactions between signaling pathways and transcriptional networks promote the differentiation of all the cell types of the Drosophila eye. The goal is to uncover mechanisms that will both explain genetic diseases of the eye, and improve our ability to design cell replacement therapies.